COMPARISON OF THE RESPONSE TO THERAPY WITH GAMMAR IV OR PLACEBO

The study will compare the response to therapy of patients with chronic inflammatory demylinating polyreadiculoneuropathy (CIDP) with either intravenous immune globulin or placebo (5% albumin) using average muscle strength score as the primary efficacy variable.